A Multi-omics evaluation of Carfilzomib-related Cardiotoxicity

Cardiotoxicity related to cancer therapies is such a significant clinical problem that NCI and NHLBI have jointly
issued PA-19-112 to stimulate applications with the intent to mitigate cardiovascular dysfunction while optimizing
cancer outcomes. Cardiotoxicity, such as heart failure (HF), related to the proteasome inhibitor carfilzomib has
been an increasingly recognized adverse event that contributes to the symptom burden and poor outcomes of
multiple myeloma (MM) patients. Given the knowledge gap in the understanding of carfilzomib-related
cardiotoxicity, a pharmacogenomic approach may identify pharmacogenomic/metabolomic biomarkers of such
adverse effect and provide an opportunity to improve cardiovascular outcome of cancer patients in a
personalized manner. Our long-term goal is to identify and institute preventive strategies for cancer patients at
high risk for carfilzomib-related cardiotoxicity, prior to administration of this cardiotoxic treatment, in order to
prevent or minimize such risk. Our central hypothesis is that characteristic biomarkers for carfilzomib-related
cardiotoxicity can be discerned through interrogation of multi-omics data. Our preliminary results demonstrate
the feasibility of such an approach and suggest that the metabolomic and proteomic profiles of carfilzomib-related
HF are similar to those of HF in non-cancer patients. More importantly, our findings support the hypothesis that
there are overlapping pathways in the development of cardiotoxicity induced by carfilzomib and anthracyclines.
The overall objectives of this application are to identify and validate metabolomic and pharmacogenomic
biomarkers for carfilzomib-related HF in MM patients using a multi-omics approach and existing whole exome
sequencing (WES) data from the Oncology Research Information Exchange Network (ORIEN), and in large
electronic health record (EHR) systems, namely the UK Biobank and biobank at Vanderbilt University (BioVU).
We have assembled a multidisciplinary team to carry out the following three specific aims: 1). Identify and
validate metabolomic biomarkers at baseline that differentiate MM patients who develop versus do not develop
carfilzomib-related HF. 2). Identify and replicate germline genetic variants associated with carfilzomib-related HF
among MM patients. 3). Build and validate a predictive model for carfilzomib-related HF among MM patients.
The proposed work is expected to provide tools to enable stratification of MM patients for cardiotoxicity risk
based on pharmacogenomic and metabolomic biomarkers and provide the basis for clinical translation of these
biomarkers. In addition, this work will also provide important insight as to what extent the genetic variants
associated with anthracycline-related cardiotoxicities are also associated with carfilzomib-related HF. Ultimately,
our research will potentially lead to a paradigm shift in current clinical practice to better prevent cardiotoxicity,
and improve outcomes in the MM patient population.

Public health relevance
Project Narrative Cardiotoxicity, such as heart failure, related to proteasome inhibitor carfilzomib has been an increasingly recognized adverse event for patients with multiple myeloma. We propose to identify and validate pharmacogenomic/metabolomic biomarkers for carfilzomib-related heart failure and create a predictive model to enable stratification of multiple myeloma patients in order to minimize the risk of cardiotoxicity. The proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reducing morbidity and mortality in the overall US population.